KYC, an inhibitor of sickle cell disease's vicious cycle in vaso-occlusive crisis and pain

The work in this proposal will develop a novel drug candidate for treating vasculopathy (VP)/vasocongestion
(VC), vaso-occlusive crisis (VOC) and pain in people who have sickle cell disease (SCD). SCD is a complex,
multifactorial disease process that causes acute, painful episodes of life-threatening VOC. It has been described
as a vicious cycle, where hemoglobin (Hb) polymerization leads to impaired red blood cell (RBC) rheology, which
increases VC and hemolysis. Cell-free Hb (cf-Hb) is considered a primer for VOC because it scavenges nitric
oxide and increases endothelial adhesion. However, it is the RBC VC and heterocellular aggregates that cause
and accelerate microvasculature stasis and ischemia/reperfusion (IR) injury and has the most significant impact
on SCD severity. N-Acetyl-lysyltyrosylcysteine amide (KYC) is a first-in-class, systems chemico-pharmacology
drug (SCPD) with multiple mechanisms of action that inhibit VP and reduce VC and pain in SCD mice. KYC
inhibits vasculopathy by restoring endothelial-dependent vasodilation and reducing VC in SCD mice. KYC
inhibits hemoglobin S (HbS) oxidation in vitro and reduces blood viscosity and the percentage of sickled RBC in
SCD mice within just one hour of treatment. As RBC sickling, VC, and VP all precede VOC and pain, we request
funding to develop KYC for treating SCD patients presenting to the emergency department suffering from VOC
and pain. Currently, no widely used FDA-approved therapies exist for treating VOC and pain in SCD patients.
This application will obtain data showing KYC reduces VP, VC, VOC, pain, and irreversible sickling and VP at
baseline and after hypoxia/reoxygenation (HR) injury. After halting KYC therapy, we will determine the time
required to return to baseline SCD severity. Pharmacokinetic (PK), pharmacodynamic (PD), safety and pathology
data will demonstrate that KYC is a safe, effective drug that reduces VOC and pain in SCD mice. In Aim 1, we
will determine if KYC reduces VP, VC, VOC, and biomarkers of SCD severity better than voxelotor in SS mice.
We will determine the time it takes for SCD mice to return to baseline after halting KYC. VC in tissue sections
will be quantified, informing us of KYC’s efficacy for reducing multiple organ injuries. Microvascular stasis, an
index of VOC, will be determined using dorsal skinfold window chambers. HbS polymerization will be determined
by oxygen scanning ektacytometry. Blood viscosity, vasodilation, VC, and VOC will be determined at baseline,
after H/R injury, and after halting KYC. We will determine the extent to which KYC reduces VC in organs using
established protocols and pain in Townes SS mice before and after HR injury and after halting KYC. In Aim 2,
we will determine subcutaneous (SQ) KYC PK-PD and safety. Preliminary studies suggest KYC has excellent
SQ bioavailability in healthy mice. We will also determine in vivo SQ KYC biodistribution, PK-PD, various
standard safety measures, biological stability properties, and metabolism in adult AA and SS mice.

Public health relevance
Project Narrative Sickle cell disease causes hemolytic anemia and intermittent vasocongestion that can develop into “acute crises." These crises lead to severe pain, chronic organ injury, neurological deficits, and even death. This application aims to develop a novel drug that restores vascular function, prevents acute crises and alleviates pain.